Maturation of inhibitory circuits in the gustatory cortex and expression of taste preference

Project Summary
As animals transition from relying on their mother’s milk to foraging and consuming foods, they experience
an abundance of new tastes. These experiences regulate taste preference later in life through a process which
likely relies on plasticity in neural circuits associated with taste and feeding. The gustatory cortex (GC) is involved
in processing tastes and is required for taste-motivated behaviors as well as learning about tastes. How these
early experiences affect the development of taste preferences or the maturation of GC circuits has not been the
subject of investigation. Maturation of inhibitory circuits in other primary sensory systems is a hallmark of
postnatal development. This proposal will investigate the role of taste experience in shaping later taste
preference, whether a postnatal sensitive window exists in which experience shapes taste preference, and the
cellular- and circuit-level GC physiology which is sensitive to taste experience, with a focus on inhibition. The
first part of the proposal will examine how taste preferences mature from juvenile to adult ages. The role of taste
experience at the time of weaning versus in adulthood in modulating taste preference will also be examined.
Maturation of inhibitory networks within the GC will be examined by quantifying parvalbumin-positive inhibitory
neurons, their connection strength onto pyramidal neurons, and the total spontaneous GABAergic synaptic
transmission onto pyramidal neurons in the GC from pre- and post-weaning ages. The role of taste experience
on inhibitory maturation will also be examined. Finally, the relationship between the maturation of inhibition and
the development of taste preferences will be assessed by chemical disruption of stabilizing proteins on
parvalbumin-positive neurons. These studies will elucidate the necessity of a mature inhibitory circuit in GC for
the behavioral expression of taste preference as well as whether a sensitive window exists in which experience
shapes taste preference. While mechanisms underlying learning about the value or physical cues associated
with tastes has been investigated in adulthood, the postnatal mechanisms leading to such a refined circuit have
not been described. The results of these studies will indicate the role of early food experiences in determining
taste-based choices throughout life.

Public health relevance
Project Narrative As mammals transition from relying on their mother’s milk for sustenance to consuming foods, they experience an abundance of new tastes. Such early taste experience can affect taste preference throughout life, but the brain mechanisms regulating the effect of experience during postnatal development are not understood. This proposal addresses this question by examining developmental and experience-dependent changes in inhibitory circuits in the gustatory cortex and the effects these changes have on taste preference. The functioning of the gustatory cortex as a mature structure is required for learning about taste stimuli and for taste-motivated behaviors; thus when these circuits become perturbed in diseases such as eating disorders, improper taste- related decisions and food choices can be made.